Investigating the roles of extracellular cGAMP and harnessing it for cancer treatment

PROJECT SUMMARY
The goal of cancer immunotherapy is to awaken the body’s anti-tumoral immune response to fight against
all cancers in all patients. Our lab recently identified a key mechanism by which cancer cells are detected by our
innate immune system. We now know that cancer cells, with intrinsic chromosomal instability, constantly secret
the soluble small molecule 2’3’-cyclic-GMP-AMP (cGAMP). Acting as an immunotransmitter, extracellular
cGAMP is taken up by surrounding tissues and immune cells to activate its receptor STING in a paracrine fashion,
resulting in downstream anti-cancer immune responses. The importance of extracellular cGAMP is demonstrated
by our finding that it is required for the curative effect of ionizing radiation in a murine model of breast cancer.
Furthermore, we identified the extracellular enzyme ENPP1 as the only detectable hydrolase of extracellular
cGAMP that blocks its signaling pathway. Therefore, we hypothesize that ENPP1 is an innate immune
checkpoint that could be targeted to expand the reach of cancer immunotherapy.
Although ENPP1 is cGAMP’s only hydrolase, it hydrolyzes extracellular ATP at comparable potency.
Therefore, genetic and pharmacological tools that are based on complete ablation of ENPP1 activity cannot be
used to distinguish the physiological role between extracellular cGAMP and ATP. Here, we propose selective
genetic and chemical biology approaches: we will characterize genetic tools that selectively abolish ENPP1’s
hydrolase activity toward extracellular cGAMP but not ATP (dENPP1cGAMP); in parallel we will develop substrate-
specific ENPP1 inhibitors as tool compounds and potential immunotherapeutics.
In Aim 1, we will fully characterize the kinetics, selectivity, and mechanisms of action of mutant
dENPP1cGAMP, as well as the pathophysiology of dEnpp1cGAMP mice. In Aim 2, we will evaluate multiple tumor
models in the dEnpp1cGAMP mouse strain to determine the physiological roles of extracellular cGAMP in
controlling tumor growth and synergism with checkpoint blockers. In Aim 3, we will first characterize mechanism
of substrate selectivity of our lead cGAMP-selective ENPP1 inhibitor and then use this inhibitor to harness the
anti-tumoral effects of extracellular cGAMP. This proposal combines careful biochemical analyses with mouse
genetics and tool compound development to address the role of extracellular cGAMP in cancer, with the goal of
improving cancer immunotherapy.

Public health relevance
Project narrative Although cancer immunotherapy has revolutionized the treatment of advanced cancers, it only benefits patients with immunologically “hot” tumors, partly because we have not taken advantage of anti-cancer innate immunity. We recently identified cGAMP as a key danger signal that cancer cells send to our innate immune system in response to intrinsic DNA damage, and we have also uncovered how cancers overcome this detection by overexpressing the enzyme that degrades this signal. Here we propose to fully characterize the effects of extracellular cGAMP on cancer development and to develop strategies to selectively prevent its degradation in tumors, with the goal of identifying targeted anti-cancer immunotherapies with minimal side effects.